QUANTITATIVE VISUALIZATION OF PHASE CHANGE PHENOMENA

This project aims at the visualization via MRI of freezinginterfaces in ice-water mixtures. Specifically, the in-situvisualization of frost and of freezing in porous media will bepursued. MRI is the only solution possible in such systems thatare strongly refracting to light. Attendant MRI thermometrystudies will also be pursued.